Biostatistics and Bioinformatics Core

Project Summary – Bioinformatics and Biostatistics Core C
The Biostatistics Core has been an integral part of the first Wistar/UPenn SPORE in Skin Cancer (2001-2009;
2014-2019). Core C functionality and interaction with skin cancer researchers on both campuses has remained
intact throughout the last 19 years resulting in many high impact publications, reporting key advances in
melanoma. To meet the changing needs of the Projects and anticipated needs of the Pilot Programs, Core C
has become the Biostatistics & Bioinformatics Core. Core C key personnel will continue to play a critical role in
the statistical design, statistical analysis, and dissemination of research results for all experimental and clinical
studies defined within the Projects, as well as the Career Enhancement Program (CEP) and Developmental
Research Programs (DRP) research activities. The members of this core include two senior biostatisticians and
a bioinformatician, who have complementary expertise, extensive collaborations with SPORE investigators,
knowledge of new developments in biostatistical and bioinformatics methods and their application to research
proposed in the SPORE, and an extensive publication record that reflects their expertise in melanoma and other
skin cancers. The biostatisticians are members of the Division of Biostatistics of the Department of Biostatistics
and Epidemiology and are part of the Biostatistics Shared Resource of the Abramson Cancer Center at the
University of Pennsylvania. The bioinformatician is a faculty member of the Wistar Institute. The Biostatistics and
Bioinformatics Core key personnel will provide expertise and experience in five key areas. The first is to provide
a robust computational and data management environment for datasets developed by the research projects and
the Biospecimen and Pathology Core (Core B). The second is to provide expertise on research methodologies
to design and implement rigorous laboratory studies, biomarker studies and clinical trials. The third is to provide
expertise on statistical methodologies critical to each research project. These activities include plans for the data
preprocessing and analysis for big data discovery studies, testing proposed statistical hypotheses as well as the
development of statistical models. The fourth is to conduct evaluations of different methodologies to identify the
most effective approach, developing new methods when standard methods are not appropriate, and to conduct
discovery studies using archived public databases relevant to the research projects. The fifth is to provide expert
interpretation of research data and collaboration with Project investigators to make scientifically and statistically
appropriate statements, as well as to assist in the preparation of scientific abstracts, presentations, and
manuscripts. All of the Core C key personnel have played a major role in designing the Projects in this SPORE
application, and expect to play an instrumental role in the success of the next cycle.

Public health relevance
Project Narrative – Biostatistics and Bioinformatics Core C Collaboration between the Biostatistics and Bioinformatics Core and the research investigators conducting SPORE-related studies will insure that the SPORE research studies will have strong bioinformatics infrastructure, high quality study designs and tailored statistical analysis plans that will provide a solid foundation for each study’s conclusions. This will ensure Scientific Rigor and enhance the impact of discoveries on the care of patients with melanoma and other skin cancers.